PROBABILISTIC ANALYSES OF NUCLEIC ACID SEQUENCES

This project has focused on the analysis of amino acid and DNA sequence data as it pertains to molecular biology and molecular evolution. Areas of interest have included: The description of measures of similarity appropriate for protein sequence comparison; the development and analysis of algorithms for multiple sequence alignment and their implementation as useful software; the formulation and solution of mathematical problems with relevance to biological sequence comparison; the analysis of biological sequence data for evolutionary and functional relationships.